Mechanism of Skeletal Muscle Calcium Dysregulation in Myotonic Dystrophy

ABSTRACT:
Key components of skeletal muscle that regulate excitability and excitation-contraction coupling (ECC) undergo
major shifts of isoform expression during development. This process of perinatal ECC remodeling is highly
conserved throughout vertebrate evolution and results mainly from post-transcriptional mechanisms in which
alternative splicing of specific exons for ClC-1, CaV1.1, RyR1 and SERCA1 occurs. In myotonic dystrophy (DM),
these splicing switches revert to their fetal set points due to sequestration of MBNL splicing factors in nuclear
RNA foci. We used gene editing to recreate individual DM splicing defects in mice and systematically analyzed
mice for effects in isolation and in combination through breeding. Our preliminary studies indicate that loss of
ClC-1 function combined with CaV1.1 exon 29 exclusion (Cav1.1∆e29), comparable to that observed in DM
patients, results in severe muscle weakness and respiratory deficits and is lethal in mice by age ~9 wks. This
effect is rescued by long-term treatment by oral feeding with a Food & Drug Administration (FDA) approved
calcium channel blocker. Here we propose studies to define mechanisms and explore the possibility that drug
treatments that target myotonia and Cav1.1 channels can mitigate muscle weakness in DM. In Aim 1 we will
investigate the mechanism for the early demise of myotonic Cav1.1∆e29 mice, including the study of how
Cav1.1∆e29 channels impact membrane excitability and Ca2+ homeostasis, and downstream effectors that include
calpain, transcription and mitochondrial health. Further, we will determine if myotonic Cav1.1∆e29 mice exhibit
skeletal muscle weakness and altered respiratory function. In Aim 2 we will treat myotonic Cav1.1∆e29 mice by
oral feeding of FDA approved drugs that target the calcium channel or myotonia by factorial design (one, the
other, both or neither) to see which treatment is most effective at extending life and improving muscle and
respiratory function. In Aim 3 we will move the treatment into a CUG repeat expansion DM1 mouse model that
exhibits severe muscle weakness, myopathic features and shortened lifespan. We will use a series of non-
invasive techniques to measure muscle and respiratory function to determine treatment benefit in longitudinal
studies. The ultimate goal of this proposal is to identify DM1 therapeutic interventions that can be rapidly
transitioned to the clinic.

Public health relevance
Project Narrative: Myotonic dystrophy is the most common dystrophy in adults, where muscle weakness resulting in respiratory failure is the leading cause of mortality. This proposal studies the mechanisms responsible for muscle weakness with focus on dysregulated calcium homeostasis and excitability. Results from this study will provide important insight into understanding DM1 pathogenesis and lay the groundwork for development of future therapeutic interventions.